Administrative Core

SUMMARY
The goal of the Harvard-wide Program on Antibiotic Resistance is to apply innovative advanced
technologies to developing new strategies for treating leading causes of multidrug resistant
hospital-associated infection caused by staphylococci and enterococci. This multi-investigator
project brings together experts from fields ranging from mathematics and systems biology to
infectious disease clinicians, and the Administrative Core creates an infrastructure for them to
work collaboratively and synergistically, bringing new insights and capabilities to bear in solving
the leading public health crisis of antibiotic resistant infection. The Administrative Core functions
as a central resource for facilitating interaction among Subproject and Core Investigators, to
ensure program synergy, executing and tracking subcontract expenditures to ensure efficient
project performance, recording and compiling records to track and manage progress, connecting
the Program Project to other initiatives to leverage its resources, and for ensuring the timely
reporting of results and financial status to NIAID Program staff. The Administrative Core will
continue to strive to foster the existing synergy in attainment of project goals and milestones. To
do this, the Administrative Core will provide program management and oversight, facilitate
interactions between participants, provide critical infrastructure for fiscal management of the
program, provide connectivity to and leverage from other Harvard-wide initiatives, including the
Microbial Sciences Initiative (MSI) and Catalyst Clinical and Translational Sciences Center, and
provide a single point of contact and active coordination for on-going communication with NIAID
and the Program Officer, and other NIAID initiatives, including data sharing. As a result of internal
and external synergies, the impact of the Harvard-wide Program on Antibiotic Resistance is much
greater than would otherwise be possible through individual research efforts.

Public health relevance
NARRATIVE The Harvard-wide Program on Antibiotic Resistance is designed to fill critical gaps in knowledge that will allow new approaches for treating serious infections with antibiotic resistant staphylococci and enterococci to be developed. The Administrative Core provides overall coordination and orchestration of this effort, and facilitates sharing results from this project with the scientific community to catalyze progress in addressing the global health crisis of antibiotic resistance. This is done by creating structures that enhance the synergistic interaction among a multidisciplinary team, and that insure the rigorous execution of the experimental plan in a manner that is fully transparent, accountable, and authenticated.